Exploring a Risk Phenotype for Maternal Distress Characterized by Regulatory Focus

PROJECT SUMMARY
Both high incidence (i.e., 15%) and low remission rate (i.e., 30-50%) of postpartum distress symptoms indicate
a need for more research on the underlying mechanisms associated with elevated maternal distress and
caregiving deficits. Severe symptoms of maternal distress will continue to inflict significant morbidity and elicit
poor child health outcomes unless we initiate a system-wide change in how nurses and other healthcare
professionals understand and recognize indicators of maternal distress. Prior research has determined that
mothers with elevated distress symptoms (e.g., irritability and anhedonia) display suppressed neurological
reward responsivity. However, few studies have examined the role of reward responsivity to loss and
caregiving behaviors. Even fewer studies have asked women to describe their experience with goal pursuit
during the postpartum period and perceived functional ability as a mother. To address this research gap, the
proposed study will apply the Regulatory Focus Theory to link both aberrant reward responses and disruptive
caregiving behaviors to specific distress symptom sets assessed with the Inventory of Depression and Anxiety
Symptoms (IDAS) self-report measure. Aim 1 will use a retrospective, secondary analysis to correlate fMRI
imaging data with IDAS scores to determine distinct symptom sets that are associated with suppressed reward
responsivity. Aim 2 will use prospective, mixed-methods analyses to correlate maternal caregiving behaviors
with IDAS scores and qualitative interviews from a subset of 12 mothers. Exploratory Aim 3 will interpretively
synthesize findings from Aims 1 and 2 to propose an initial risk phenotype for maternal distress. This initial step
toward developing a risk phenotype will guide future research to improve early detection of women most
vulnerable to developing debilitating symptoms of distress during the postpartum period. The proposed study
and associated research training provide a comprehensive foundation for an innovative program of nursing
research focused on the bidirectional nature of the caregiver-child relationship as it relates to Regulatory Focus
Theory, specifically whether enhancing maternal self-regulation can prevent child development disorders.

Public health relevance
PROJECT NARRATIVE A more comprehensive understanding of the underlying mechanisms associated with elevated maternal distress and caregiving deficits is necessary for early detection, care management, and effective treatment options during the immediate postpartum period. This study will explore a risk phenotype for maternal distress by analyzing neurological changes in reward responsivity, caregiving behaviors, and the maternal experience of goal pursuit and perceived daily functioning in postpartum mothers. Outcomes of this project will support future work on the bidirectional nature of the maternal-child relationship as it relates to Regulatory Focus Theory, and lead to improvements in postpartum care and intervention development.